Outpatient Palliative Care and Prescribing Safety and Quality at End-of-Life

Background: The long-term goal of this research is to support the ability of Veterans with life-limiting conditions
(LLCs) to remain living their communities by ensuring access to the highest possible quality of care; including
long-term care support services like palliative care. Given their complex healthcare needs, Veterans with LLCs
often manage many different medications, each carrying their own risk/benefit profile. Unfortunately, complex
medication regimens are a significant risk factor for receiving potentially unsafe medications or being over-
treated for chronic conditions such as high cholesterol and diabetes.
Significance/Impact: A key component of palliative care that can assist Veterans is ensuring that medication
therapy is aligned with patients’ and families’ goals of care. Palliative care, therefore, provides a critical
opportunity to deprescribe or de-intensity potentially harmful or unnecessary medications. Outpatient palliative
care (OPC) is a growing community-based medical service known to improve access to palliative care for
patients living in the community. OPC is also underutilized, and little is known about potential barriers to receiving
OPC services.
Innovation: Our study is highly innovative 4 key ways: (1) outpatient palliative care is a relatively new,
community-based, long-term care service offered to Veterans, and OPC is still underutilized across the VA; (2)
It is the first study to evaluate the comparative effectiveness of OPC versus usual care in the VA; (3) Veterans
with LLCs prefer to remain in non-institutional settings. However, community-based care is not covered by the
regulations that monitor the quality of care in their nursing home counterparts. This research is therefore essential
for developing community-based performance metrics to monitor the quality of care in community-dwelling
Veterans with LLCs; and (4) VA policy directives state that VA palliative care teams are necessarily
multidisciplinary. This mixed-methods study is novel in its use of semi-structured interviews that will include
different provider-types comprising a palliative care team and VISN Palliative Care Program Managers.
Specific Aims: The specific aims are to: (1) determine the extent to which variation in OPC use exists across
VA facilities, and identify patient- and facility-level factors that contribute to this variation; (2) evaluating the
comparative effectiveness of OPC (versus traditional outpatient care use) on deprescribing of potentially unsafe
medications (PUMs), and deintensification of unnecessary chronic disease medications in Veterans with LLC;
and (3) explore the perspectives of VA palliative care providers and deignated VISN Palliative Care Program
Mangers about barriers and facilitators to using OPC and to effectively addressing the deprescribing unsafe or
unnecessary medications in Veterans with LLCs.
Methodology: The quantitative phase of this mixed-method study will involve analyses of VA and Medicare data
in over 2,000,000 Veterans with LLC. Pooling data from 2010-2018, we will link inpatient, outpatient, nursing
home, vital status, and medication data from VA and Medicare to develop a national cohort of Veterans with
LLCs. Our analytic approach involves propensity score weighting and instrumental variables to address potential
selection bias associated with OPC use. The qualitative phase will involve semi-structured interviews of VA
outpatient palliative care providers to assist in interpreting quantitative results and gain additional insights about
barriers to OPC use and challenges with managing medications.
Next Steps/Implementation: Together, these aims will assist both VA and non-VA healthcare systems in
making evidence-based decisions about improvements and expansions to OPC services, and to better design
policies and interventions to ensure safe and effective medication use at end-of-life.

Public health relevance
This project aims to inform policies and interventions designed to improve the quality of medication prescribing in Veterans with life-limiting conditions, by examining the impact of VA outpatient palliative care visits on use of potentially unsafe medications and overtreatment of common chronic illnesses. This important step towards the long-term goal of supporting the ability of Veterans to remain in their homes and communities by ensuring access to the highest-quality end-of-life care addresses three national VA priorities: reducing adverse drug events; expanding community-based alternatives to institutionalized care; and providing evidence- and value-based palliative care and hospice care.